Targeting the Integrated Stress Response to Protect Oligodendrocyte lineage Cells

The focus of the studies funded by this award over the past two decades has been on the response of
oligodendrocytes to inflammation. This work is of critical relevance to the immune-mediated demyelinating
disorder multiple sclerosis, which is characterized by CNS inflammation, oligodendrocyte loss, demyelination
and axonal degeneration. Our studies have shown that oligodendrocytes respond to inflammation by activating
the integrated stress response (ISR), which is a highly conserved, cytoprotective response that initiates with the
phosphorylation of the eukaryotic translation initiation factor 2 alpha (eIF2α). We have demonstrated using
genetic models that oligodendrocytes with a diminished capacity to phosphorylate eIF2α in response to stress
display increased susceptibility to inflammatory insults and that prolonging the phosphorylated state of eIF2α in
oligodendrocytes increases their resistance to inflammation, both in vitro and in mouse models of inflammatory
demyelination. This work has provided the foundation for an effort to protect oligodendrocytes from inflammation
by pharmacologically enhancing the ISR. In contrast, recent reports indicate that that the inhibition of the ISR
pathway provides protection in certain neurological disorders. Moreover, our unpublished work indicates that
oligodendrocytes experiencing ER stress activate a distinct cytoprotective response from oligodendrocytes
challenged by mediators of inflammation. The studies described in the current proposal are designed to uncover
the molecular origin of this dichotomy. In aim 1 we will carry out a detailed characterization of the oligodendroglial
stress response in Jimpy mutant mice, which represent a mouse model of the human leukodystrophy Pelizaeus-
Merzbacher disease. Jimpy oligodendrocytes experience severe ER stress, and our preliminary data indicates
that inhibiting ISR activation in these animals provides significant protection to oligodendrocytes. In aim 2 we will
directly compare the various aspects of the response of oligodendrocytes experiencing ER stress with
oligodendrocytes exposed to inflammation. Aims 3 and 4 will be devoted to an effort to determine if the activation
of non-canonical cytoprotective responses explain the differential response of oligodendrocytes to ER stress and
inflammation. In aim 3 will examine the contribution of NRF2, which is phosphorylated by the stress-sensing
kinase PERK, to these responses. In aim 4 we will examine a recently discovered ER stress response pathway
that is triggered by the cell migration inducing hyaluronidase 2 (TMEM2), which is of potential relevance to
myelinating and remyelinating oligodendrocytes. Together the work described in this proposal will significantly
advance our understanding of the response of oligodendrocytes to various cytotoxic insults, which will provide
important information critical to the development of neuroprotective therapies for oligodendrocytes and other
cells of the nervous system.

Public health relevance
Project Narrative The proposed research study is relevant to public health because it focuses on neuroprotection, which is an emerging therapeutic strategy for myriad neurological disorders. Our studies will explore the molecular basis of cellular protection provided by innate intracellular stress response pathways, with an emphasis on oligodendrocytes, the myelinating cells of central nervous system.